Mitochondrial TDP-43 in Alzheimer's Disease

PROJECT SUMMARY Alzheimer's disease (AD) is the leading cause of dementia in the elderly, characterized by neurofibrillary tangles, senile plaques and a progressive loss of neuronal cells in neocortex and hippocampus. Currently, there is no effective treatment for AD. Genetic mutations in TAR DNA-binding protein 43 (TDP-43) cause amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD, the second most common form of early-onset dementia), and the increased presence of TDP-43 in the cytoplasm is a prominent histopathological feature of degenerating neurons in more than half of AD patients. Despite an expanding body of evidence suggests that TDP-43 may be “the third protein” playing a distinct role in the pathogenesis of AD or related dementia, in addition to amyloid beta (Aβ) and tau, the molecular pathomechanisms of TDP-43 remain elusive. Interestingly, in our preliminary studies, we found that TDP-43 became highly associated with mitochondria in AD patients, neurons treated with Aβ and APP/PS1 (5XFAD) transgenic mice for AD. Based on identified motifs critical for TDP-43 mitochondrial localization, our most recent study revealed that the suppression of TDP-43 mitochondrial localization was sufficient to prevent TDP-43-induced neuronal loss, and improve behavioral performances in TDP-43 transgenic mice, indicating mitochondria as important mediators for TDP-43 neurotoxicity. Excitingly, the inhibition of TDP-43 mitochondrial localization could significantly alleviate neuronal death and behavioral deficits in 5XFAD mice well after symptom onset. These exciting and promising preliminary studies suggest that a detailed investigation into the potential role of mitochondria- associated TDP-43 in AD and related dementia is warranted. Using both cultured neuronal and transgenic mouse models for AD and related dementia, this study will test the feasibility of targeting mitochondria- associated TDP-43 as a novel therapeutic approach for AD and related dementia. The increased presence of TDP-43 in the cytoplasm is a prominent common histopathological feature of degenerating neurons in various major neurodegenerative diseases including AD, FTD and ALS. Our proposed studies of mitochondria- associated TDP-43 and its connection with the generally believed AD culprit Aβ will have very broad scientific and translational significance.

Public health relevance
Narrative The cytoplasmic mislocalization of TDP-43 represents a distinct key and common pathological feature of degenerating neurons in patients with Alzheimer’s disease (AD) or related dementia. Our most recent study has revealed that, like amyloid-β peptide (Aβ), TDP-43 could be present in mitochondria and mediates TDP- 43-induced mitochondrial dysfunction and neuronal loss in amyotrophic lateral sclerosis or frontotemporal dementia. Based on pilot studies showing increased mitochondria-associated TDP-43 in AD patients and experimental models and, importantly, the prevention of Aβ toxicity by inhibiting TDP-43 mitochondrial localization, we will use a new mitochondria-associated TDP-43 sensor and a novel transgenic mouse model inhibiting TDP-43 mitochondrial localization to test whether the suppression of TDP-43 mitochondrial accumulation could be a new therapeutic strategy for the treatment of AD and related dementia.